Genetic Control of Phrenic Motor Neuron Development and Maintenance

Project Summary/Abstract
Respiratory dysfunction is both a risk factor and a common symptom in Alzheimer’s disease (AD), but the
molecular mechanisms that underlie this pathology are not well understood. AD patients exhibit phosphorylated
tau accumulation in the brainstem and cervical spinal cord, which contain neurons critical for breathing, at
preclinical stages but the impact of these changes on respiratory circuit function is not clear. It is also not known
how respiratory dysfunction contributes to the progression of AD pathology. In this supplement, we will examine
changes in respiratory circuit connectivity and function with aging and in the PS19 AD mouse model, in order to
begin to understand the link between respiratory dysfunction and AD progression. Our data will reveal both novel
risk factors and potential future therapeutic targets for AD.
In Aim 1 we will define changes in respiratory neuron connectivity and function with aging and in the PS19 AD
mouse model.
In Aim 2 we will determine transcriptomic and epigenetic changes in respiratory neuron populations over time in
control and PS19 mice to elucidate age-related risk factors and AD-induced changes.
We will utilize a combinatorial approach established in our lab as part of the parent award for interrogating
respiratory circuits. We have developed an integrative methodology combining genetic models, single-cell RNA-
sequencing, ATAC-sequencing, expansion microscopy, retrograde viral tracing, and behavioral assays, such as
plethysmography, to address these questions in vivo. Our approach has the potential to reveal novel therapeutic
targets by investigating a vital, yet understudied, circuit implicated in AD progression.

Public health relevance
Project Narrative Respiratory dysfunction is both a risk factor and a common symptom in Alzheimer’s disease (AD), but the molecular mechanisms that underlie this pathology are not well understood. In this supplement, we will examine changes in respiratory neuron gene expression, connectivity and function with aging and in the PS19 AD mouse model, in order to begin to understand the link between respiratory dysfunction and AD progression and identify novel therapeutic targets.